EXERCISE TRAINING IN MEN AND WOMEN WITH NONINSULIN DEPENDENT DIABETES MELLITUS

This study will examine the effects of an eight week aerobic exercise training program (65% VO2 Max) in men and women with non-insulin dependent diabetes mellitus on 1) insulin sensitivity measured immediately and 24 hours after a bout of exercise; 2) selected qualitative and quantitative changes in lipid and lipoprotein in metabolism; 3) hemostasis measured by indices of fibrinogen and fibrinolysis; and 4) quality of life.